Improving the accuracy of malaria surveillance with serology and parasite genetic data

Project Abstract
Despite the critical need for high quality data in order to plan, implement, and evaluate malaria control
interventions, malaria surveillance is particularly poor in high burden countries such as Uganda. Malaria
molecular surveillance (MMS), which evaluates parasite DNA and host antibodies present in biological
samples to derive epidemiologically actionable information, has the potential to improve upon current
surveillance methods; however, there is limited use of these data outside of the research setting. A current
research priority is to understand how serologic and parasite genetic data can be used to enhance routine
malaria surveillance methods and evaluate malaria control interventions. Recently, our team was funded to
directly measure malaria incidence via enhanced passive surveillance within the catchment areas around 64
health facilities throughout Uganda. These 64 clusters will then be randomized to receive one of two types of
novel bednets, and cross-sectional surveys will be performed at each site 12, 24, and 36 months after the roll-
out of the intervention has been completed. This K23 project offers an outstanding opportunity to leverage
samples from cross-sectional surveys at these 64 sites to test the hypothesis that MMS will enable us to
estimate malaria incidence with more accuracy than parasite prevalence (PfPR), using enhanced incidence
data as the gold standard. Our approach will be to use established molecular techniques, including multiplex
serologic assays, qPCR, and amplicon deep-sequencing, to generate molecular metrics from samples
collected in these cross-sectional surveys; we will then build statistical models using these molecular metrics
as variables to estimate incidence as the outcome. Aim 1 is to use serologic metrics to improve the estimation
of malaria incidence in children <5 years compared to standard models based primarily on PfPR. Aim 2 is to
use parasite DNA-based metrics to improve the estimation of malaria incidence in children <5 years compared
to standard models based primarily on PfPR. In Aim 3, we will identify the set of MMS metrics that best
estimates changes in incidence over time to determine how changes in MMS metrics (both serologic and
parasite DNA-based) between each survey timepoint can be used to accurately predict changes in incidence
from year to year at each site. To complete this project, I will need additional mentorship and training in
seroepidemiology and biostatistical methods in addition to field experience in public health and surveillance
activities as outlined in this proposal. This K23 award will provide the crucial link in my transition from a
laboratory scientist to achieving my career goal of becoming a molecular epidemiologist with a focus on public
health surveillance, with the skills to effectively utilize molecular data to evaluate, develop, and apply
population level interventions for malaria control and elimination. I will emerge from this award prepared for a
strong NIH R01 application focused on utilizing molecular data to enhance malaria surveillance in settings with
poor health infrastructure in order to better target malaria control interventions.

Public health relevance
Project Narrative Improved malaria surveillance techniques that offer higher resolution information about local and regional malaria epidemiology will be necessary to more efficiently target malaria control interventions as we work toward malaria elimination. Parasite DNA and host antibodies present in biological samples collected as part of routine surveillance activities can offer useful information about malaria burden that is not captured by routine surveillance metrics – however, there is limited data on how to best apply molecular data to improve malaria surveillance. This project hopes to fill that gap by providing an understanding of which markers are most useful to enhance routine surveillance data at the community level by appropriately risk stratifying sub-national regions over space and time.